Heading and Soccer: Understanding Cognitive Risks, Benefits, and the Potential Mediating Role of White Matter

Project Summary
This proposal for an NINDS Diversity Administrative Supplement is to support Bluyé DeMessie, who is
enrolled in the Einstein MD-PhD program. The supplement application includes a detailed plan for mentoring,
training, and career development, ultimately leading to the achievement of the PhD, with a focus on human
neuroscience in the area of sport-related brain injury. The mentoring and training program is centered on a
supplementee research project, which is highly integrated with the parent R01 project, but explores novel
aspects not addressed by the parent project aims, and in fact not addressed in the scientific field in general.
Specifically, the project will (1) Determine how cerebral blood flow is changed by exposure to repetitive
head impacts in sports (2) Assess how individual personal characteristics modify the relationship of
repetitive head impacts with cognitive dysfunction. An additional key goal of this Supplement Proposal is
for the supplementee to write and submit an F31 pre-doctoral NRSA Fellowship application to support his
continued graduate work, culminating in the MD-PhD. Development of the F31 proposal is highly integrated
into the timeline of the Supplement Proposal training plan.

Public health relevance
Public Health Relevance: Sport-related repetitive head impacts (RHI), including soccer heading, are an increasingly recognized public health problem, which have been associated with structural and functional changes typical of brain injury, even in players without history of concussion. The results of our proposed study can expand knowledge by in vivo quantification of cerebral blood flow changes due to RHI and provide insight of into the effect modification by ethnicity, race, handedness, sex, socioeconomic information, and individual histories (occupational, educational, and medical). Our significant step toward a mechanistic understanding of RHI effects can lay a foundation for evidence-based determination of RHI risk among individuals and can facilitate future studies to target mechanisms for prevention and treatment.